Cancer Genomics Shared Resource

ABSTRACT: CANCER GENOMICS SHARED RESOURCE (CGSR)
The Sidney Kimmel Cancer Center (SKCC) Cancer Genomics Shared Resource (CGSR) provides investigators
with state-of-the-art DNA and RNA analytic services through a coordinated and complementary multi-site team
composed of expert faculty and staff. The CGSR provides faculty-level experimental design consultations, state-
of-the-art laboratory services covering multiple levels of DNA and RNA analysis, education and training in
applying available technologies, and assistance with grant applications and manuscript preparation. Multiple new
sequencing instruments are in place, and new single cell and spatial sequencing technologies have been
integrated. Specifically, a NovaSeq 6000 and Hamilton NGS-Star liquid handling robot were recently installed to
increase throughput and reduce sequencing costs to SKCC investigators, while NextSeq 500 and MiSeq
platforms remain available for targeted sequencing and pilot projects. Additional new instrumentation for single
cell analysis include 10X Genomics Chromium Controller, Miltenyi Biotec GentleMACS Dissociator, and 10X
Genomics Visium platform for unbiased spatial genomics. Furthermore, state-of-the-art long-read sequencing
instruments for high-quality genome assembly, phasing, and repeat analysis are operational including the high-
capacity, high-fidelity Pacific Biosciences Sequel IIe and the flexible ultra-long read Oxford Nanopore platform.
The CGSR is led by Co-Directors Andrew South, PhD, and Brian Wigdahl, PhD. Wigdahl oversees the Drexel
University (DU) site, which focuses on long-read sequencing, microbial genome and microbiome analysis,
bioinformatic pipeline development, and preparation of diverse library types for functional genomics. South
oversees the Thomas Jefferson University (TJU) site, which focuses on single cell analysis in addition to standard
genetic and epigenetic approaches. The CGSR is located in the Bluemle Life Sciences Building (TJU) and New
College Building (DU) and is easily accessible to all SKCC investigators via a short walk (<1 mile). The Specific
Aims of the CGSR are to: 1) Provide long- and short-read DNA and RNA sequencing to SKCC investigators, 2)
Develop single cell analysis for all tissues and model systems, and 3) Provide education and training to SKCC
members, staff, and trainees. During the project period, the CGSR served 83 SKCC members, 45 (54.2%) of
which had peer-reviewed funding, representing all four Research Programs. CGSR services were utilized by 126
total users in 96 peer reviewed publications (average impact factor 12.10) and 28 grant applications.
In line with the SKCC strategic plan, IMPACT PHL, and under the guidance of the Co-Directors and advisory
boards, the CGSR has set four goals for future development: 1) Hire additional personnel to perform single cell
and spatial biology analyses and a project manager to assist with day-to-day operations, 2) Foster training
seminars focused on particular technological advancements, 3) Collaborate with other SRs to integrate
bioinformatics and microscopy into CGSR consultation and project management, and 4) Establish a user group
independent of the SAC and EAB that includes SKCC trainees to provide additional review of services.